Information Dissemination Core

A central mission of the Louisiana State University Health Sciences Center (LSUHSC) Comprehensive Alcohol-
HIV/AIDS Research Center (CARC) is to develop interdisciplinary collaborative networks that will impact alcoholand
HIV-related knowledge, attitudes, and behaviors by educating the scientific and lay communities on the
neurobiological basis and biomedical consequences of alcohol use, the risk factors and biological underpinnings
of HIV, and relevant mechanisms that link these conditions. This mission will be instituted within the CARC
Information Dissemination Core (ID Core). During current and prior CARC funding periods, we have established
extensive partnerships with institutional, local, and national leaders and entities aimed at impacting knowledge,
attitudes, and behavior of high-value populations. The activities described in this proposal are organized into
three major categories based on the following target populations: (1) those aimed at disseminating information
to a community of lay persons with HIV (PWH) and individuals at risk for HIV and/or AUD, (2) those aimed at
disseminating information and skills to in-training and practicing health care providers from an interprofessional
lens, and (3) those aimed at incorporating CARC researchers (trainees, fellows, and faculty) into innovative
research and high-value dissemination activities, thereby facilitating the achievement of our synergistic aims,
and simultaneously facilitating information dissemination across research personnel. An additional aim of the ID
Core involves focused activities that will facilitate the recruitment and training of meritorious early career
scientists into CARC labs that are focused on HIV and alcohol research, foster collaborative multidisciplinary
HIV-alcohol research at LSUHSC, and promote the dissemination of HIV/alcohol findings to extramural scientists,
including strategic partnerships with other HIV/alcohol centers. The proposed ID Core activities also leverage
and reinforce existing partnerships between CARC and institutional initiatives to empirically quantify our impact
on knowledge, attitudes, and behaviors toward HIV and AUD with a growing emphasis on educational
scholarship.

Public health relevance
LSUHSC CARC Information Dissemination Core The Information Dissemination Core develops, integrates, and disseminates resources and innovative translational discoveries related to HIV and alcohol research to connect with the community, current and future interprofessional health care providers, and a multidisciplinary group of biomedical research trainees and faculty.